Functional connectivity of a brain-scale neural circuit for motion perception

Abstract
The transformation of visual cues into appropriate behavior requires the collaboration of diverse neurons across
distant brain areas. A fundamental gap in our knowledge about these visuomotor transformations is
understanding how these neurons are functionally connected, shaping neural response dynamics that give rise
to behavioral output. This gap is due to the inaccessibility of mammalian model systems, in which simultaneous
in vivo observation and manipulations across the brain is impossible as well as a lack of real-time computational
frameworks that can capture these dynamics. Here, we plan to investigate the brain-scale functional connectivity
underlying the visually guided optomotor response (OMR) in the genetically and optically accessible larval
zebrafish. Our previous computational brain-scale models generate concrete predictions for circuit composition
and connectivity strength between functional cell classes and behavior but fail to capture the individual neural
dynamics of this system. Therefore, to generate realistic dynamic models and test these predictions, we propose
leveraging integrated methods combining streaming data analysis, volumetric two-photon microscopy,
holographic optogenetic manipulation, and training of multi-regional recurrent neural networks (RNNs). Using
patterned photostimulation of single and groups of functionally and molecularly identified neurons, while
simultaneously recording activity from other hypothesized downstream neurons, we will infer excitability, sign,
and synaptic strength from the network's response. In Aim 1, we will first define neurons both functionally and
by their neurotransmitter type across the brain including the pretectum, a conserved visual processing area. In
Aim 2, we will train biologically constrained RNNs to predict functional connectivity between these neurons,
which we will iteratively test and validate by photostimulating automatically selected neural targets while
recording resulting neural activity across the pretectum, orchestrated by our streaming analysis software
(improv). Next, we will use these integrated methods to map and model the functional connectivity of pretectal
neurons with specific, identifiable premotor spinal projection neurons hypothesized to orchestrate specific
behavioral aspects. In Aim 3, we will develop online, gradient-based RNN training of recorded neurons to permit
real-time testing and refinement of the predicted brain-wide connectivity leading to behavior in individual
zebrafish. These computationally integrated experiments will generate predictive dynamic models of how signals
from each eye are transformed into behavior. Together, this research will apply innovative computational and
all-optical technologies to decode the temporal neural dynamics underlying complex sensorimotor
processing, promising essential insights for the development of treatment strategies for neuropsychiatric
disorders that are manifested in the neural connectivity across multiple brain areas.

Public health relevance
PROJECT NARRATIVE: The goal of this project is to use innovative, integrated methodology to dissect the neural circuitry underlying the visually guided optomotor response in zebrafish. Computationally guided optogenetic stimulation and adaptive analysis will reveal the functional connectivity and role of individual neurons across the brain. This work will contribute to our knowledge of the complex functional connectivity of vertebrate brains and the eventual development of brain stimulation therapies to treat connectivity brain disorders.